Human in vivo stable isotope labeling kinetics (iSILK) to quantify brain amyloid plaque kinetics

Project summary / abstract
Given the recent FDA approval of an antibody-based drug that can remove amyloid plaques as measured
by positron-emission tomography targeting amyloid (PET-amyloid) (aducanamab1), the FDA approval of the
Precivity-AD blood test2, and applications submitted for accelerated approval of lecanemab and donanemab –
antibody-based drugs also shown to reduce plaque by PET-amyloid imaging3–5 – there is an urgent need to
better understand the natural amyloid-beta (Aβ) turnover in plaques.
The overall goal of this proposal is to quantitatively characterize the rate of Aβ turnover within plaques in
vivo, in human brain tissue at various stages of Alzheimer's disease (AD) using stable isotope labeling kinetics
(SILK). That multiple antibody-based drugs nearly completely remove plaques as measured by PET3–5, taken
together with a reduction in the rate of cognitive decline, supports a role for amyloid pathology as critical driver
of AD pathogenesis. However, the duration and possible cessation of treatment is partly dependent on whether
amyloid plaques continue to grow and turn over. Other drugs (e.g. BACE inhibitors) can stop amyloid plaque
growth with minimal reversal of plaque load (~4%/year by PET), suggesting that there is some natural slow
turnover of amyloid plaques. Drug trials and clinical use of anti-amyloid therapies thus must be based on
accurate models of natural plaque growth.
Very recently, microscopic resolution of in vivo metabolic growth of human amyloid plaques was achieved
by combining SILK with mass spectrometric-based imaging methods (“iSILK”) to better characterize protein and
peptide kinetics within brain parenchyma. Specifically, the Bateman laboratory used nanoscale secondary ion
mass spectrometry (NanoSIMS) coupled to SILK to directly image the distribution and rate of protein deposition
in plaques at the nanometer level in postmortem tissue from 3 human patients with AD6. However, NanoSIMS
imaging fails to specify which molecules contain the detected isotopes. In contrast, matrix-assisted laser
desorption / ionization (MALDI) mass spectrometry-based imaging (MALDI-IMS) allows chemically-specific Aβ
peptide imaging of pathologic structures in AD mouse models and postmortem brain, which has been pioneered
by the Hanrieder lab7–10. Consequently, the group very recently demonstrated MALDI in combination with SILK
to follow plaque formation dynamics10.
Using postmortem tissue from human patients previously labeled during life by oral ingestion of 15N-
labeled spirulina, we will characterize Aβ turnover by MALDI-IMS in brains with a spectrum of AD pathology.
These measurements will inform a compartmental model of AD-related protein kinetics starting at the
microscopic structure of the plaque and extending throughout the body, a particularly important model in the
dawning era of clinically-approved diagnostic biomarkers2, disease-modifying therapies3–5, and the critical need
for a precise understanding of the earliest signs of AD.

Public health relevance
Project Narrative Recent clinical trial results suggest that antibody-based removal of cerebral amyloid β (Aβ) plaques moderately slow cognitive decline in symptomatic AD, and the first disease-modifying therapy targeting Aβ was FDA- approved in June 20211, with other therapies on the horizon; clinically-relevant biomarkers to amyloid plaques are now in use in the clinic and are imperative to monitor the intended effects of therapy on the targets and to correlate with clinical efficacy11. However, our understanding of the kinetics of Aβ (and tau) in vivo is limited; among the different “compartments” – brain tissue, brain interstitial fluid (ISF), and cerebrospinal fluid (CSF), and blood/plasma - Aβ within brain tissue is least well characterized, but arguably the most important, and is the primary subject of our inquiry.